Role of p62-Mediated Endothelial FA-Phagy in Intracranial Aneurysms

PROJECT SUMMARY
An intracranial aneurysm (IA) is a balloon-like bulge in a weakened area of a blood vessel in the brain.
Rupture of an IA leads to a subarachnoid hemorrhage, a major cause of death and disability in stroke
patients. However, the underlying pathogenic mechanisms that contribute to IA development are poorly
understood, which greatly impedes attempts to identify novel therapeutic targets for the disease.
Cerebrovascular integrity plays a pivotal role in IA development. In particular, focal adhesion (FA), a
property that enables endothelial cells to adhere to their extracellular matrix, is required for
cerebrovascular integrity. Recently, we named FA-phagy for “selective autophagy of FA” which can
regulate FA stability. Moreover, we identified p62 as the major cargo receptor for FA-phagy in endothelial
cells. Our central hypothesis is that p62-mediated endothelial FA-phagy impairs cerebrovascular integrity
and thus contributes to IA development. This hypothesis will be tested in two specific aims: 1) determine
the role of p62-mediated endothelial FA-phagy in cerebrovascular integrity and intracranial aneurysm
development; and 2) define the cargo recognition mechanisms in p62-mediated endothelial FA-phagy.
These proposed experiments may provide a firm scientific foundation for further treating IA disease by
targeting p62-mediated cargo recognition mechanisms. Importantly, this targeting cargo recognition
mechanism may precisely interfere with a specific type of autophagy and thus shift the current paradigm
on autophagy manipulation in vascular diseases, since most inhibitors in clinical trials block autophagic
core machinery that is shared in all types of autophagy, thus leading to unwanted consequences. Our
project's aims may collectively establish anti-FA-phagy strategy as a novel therapy for IA and potentially
for many other diseases due to the loss of vascular integrity.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it provides a novel therapeutic target for brain aneurysms, a condition that leads to a high rate of disability and death in stroke patients upon rupture. In particular, our work focuses on the role of a novel degradation pathway in the development of aneurysms and anti-degradation strategy may serve as a new therapy for the disease. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to reducing the burdens of illness and disability.